Equipment Supplement to R35GM146987: Purchase of LC-MS system for high throughput isolation of bioactive natural products

Project Summary/Abstract
Natural products from bacteria, fungi, and plants have long been a rich source of molecules with fascinating
chemical structures and therapeutically-relevant bioactivities. However, due to their complex structures, it is
difficult to screen many analogs of natural products to truly understand the rules governing the relationship
between their structure and activity. In the parent award, we are addressing this challenge by developing
machine learning methods that can functionally model the structure-activity relationships (SAR) of natural
products and aid in the design of biosynthetic pathways that can synthesize natural product analogs.
The first project of the parent award applies machine learning to study natural product SARs. One approach we
take is a genetic approach, where we are validating a machine learning model we previously developed that
predicts bioactivity based on the presence or absence of biosynthetic genes in a natural product’s biosynthetic
gene cluster (BGC). One major challenge of this approach is that extractions of bacterial cultures yield a complex
mixture of metabolites and it is difficult to link individual metabolites to their BGCs or observed activity. Currently,
we are using standard bioactivity-guided fractionation to link natural products to observed activity. This is a low-
throughput and laborious process. There are technologies that can make this process faster, which generally
involve performing chromatography and collecting fractions and mass spectra in parallel, so that specific mass
features can be associated with each fraction. Then activity observed in bioactivity assays can be correlated with
specific mass features to identify which molecules are responsible for activity. This process is much higher
throughput than our current approach but it requires an LC-MS with fraction collection, and we do not have
access to an up-to-date instrument for performing this assay. This equipment supplement will allow us to
purchase the required instrument and maximize the chances that this project will be successful.
The second project of the parent award focuses on developing machine learning and other computational tools
for designing BGCs to biosynthesize novel natural product-like molecules. In this project, we will use LC-MS to
determine if our engineered biosynthetic enzymes produced the expected product. While we do have access to
core facility instruments that are appropriate for this purpose, using them is associated with an hourly fee. We
could also use the instrument we will purchase with this supplement to perform these experiments, which would
save on core facility costs allowing for more of the parent award to go to personnel and supplies.

Public health relevance
Project Narrative The parent award involves the development and application of machine learning methods that can be used to prioritize natural products with therapeutically relevant bioactivities and provide insight into natural product structure activity relationships. One challenge holding back the progress of this research is the lack of a high throughput method to tie natural products to activities observed in bacterial extracts. We propose purchasing a liquid chromatography system with a mass spectrometer detector and a fraction collector to enable the use of technologies that link specific metabolites to activities observed in bioassays.